Cervical Muscle Diagnostic and Conditioning System for Injury Rehabilitation and Prevention

PROJECT SUMMARY
Neck pain, whether from a traumatic event or of a non-traumatic nature, is a leading cause of worldwide disability.
In the US alone, medical costs associated with neck pain are the third highest bill for health-related conditions
($88 billion spent every year). Although acute neck pain resolves spontaneously over weeks and is well managed
by painkillers and muscle relaxants, 50-70% of individuals experience chronic symptoms or recurrences 1–5
years after initial neck pain resolution. Therefore, 19.1 million patients visit every year a chiropractor or physical
therapist to perform exercises for neck rehabilitation. Strong evidence supports that cervical muscle training
helps to relieve pain, restore range of motion (ROM), and reinforce the musculature of the neck to prevent
disabilities and injuries. Nonetheless, traditional rehabilitation approaches are not effective as they rely only on
a “good enough” approach rather than evidence-based methods. Current clinical guidelines involve the use of
provocative tests, Cervical Range of Motion (CROM) devices, goniometers, or hands for neck disability
diagnosis, and bands, hands, or weight pressure for conditioning and strengthening exercises. However, these
tools provide inaccurate and inconsistent data and are unsafe and inefficient to fully resolve the problem.
Orthopedic Wellness Laboratories (OWL) will change the current paradigm, introducing the first medical device
based on an innovative, adjustable resistive mechanism, for accurate and efficient evaluation and rehabilitation
of neck disabilities. The device consists of a head restraint configured to move in the sagittal, frontal, and
transverse planes linked to a multi-axis modular resistance mechanism that can be set to create resistance to
the user’s cervical motion. The device utilizes advances in technology and movement metrics to provide
quantitative, accurate, and real-time data of the patient neck range of motion in three planes and allows to safely
and precisely strengthen specific weak or injured areas without overloading them. The research proposed in this
SBIR Phase I will be focused on the feasibility assessment of OWL’s technology. In particular, OWL will develop
the first multi-axis cervical muscle prototype device designed to fit individuals with different neck and head
physical dimensions and range of motion. The prototype will be tested for comfort and ease of use by volunteer
subjects and physical therapists, and the ability to accurately measure the range of motion in a real-life diagnosis
set-up. Future SBIR Phase II will focus on the development of a product market-ready and clinical intervention
tests. Successful completion of this research will result in a new tool that will enable clinicians and physical
therapists to provide accurate diagnoses, create customized patient exercises, increase practice throughput,
identify the potential joint, disc, or skeletal dysfunctions earlier, and increase patient compliance to the neck
rehabilitation treatment.

Public health relevance
PROJECT NARRATIVE Rehabilitation of cervical muscles to cure neck pain currently relies on rudimentary, inconsistent, and low-tech methods that fail to provide long-term resolution of the problem. Orthopedic Wellness Laboratories, Inc. (OWL) is developing the first multi-axis cervical muscle conditioning and rehabilitation device, based on an innovative resistance mechanism. OWL’s unique technology will improve the management of neck pain by providing the clinician the ability to quantify baseline motion metrics (injured or weak muscles and asymmetric motion) within each plane individually, develop customized conditioning plans per the patient’s specific needs, and track performance metrics with time to enhance patient compliance.